Bone Marrow Spatial Transcriptomics to Enhance In Vitro Platelet Production

ABSTRACT
Platelet transfusions play life-saving roles for cancer therapy, bone marrow transplantation, bone marrow failure,
sepsis, genetic platelet disorders, and other diseases. However, the limited shelf life of donor platelets causes
frequent shortages. In addition, multiply transfused patients often become allosensitized making them refractory
to treatment. The development of induced pluripotent stem cell (hIPSC) technology has raised the intriguing
possibility of producing platelets in vitro for clinical use. This would provide a relatively limitless supply of on-
demand platelets, including personalized and HLA matched/engineered products. However, current in vitro
differentiation protocols fail to generate platelets at high enough efficiency for practical use. The major bottleneck
involves the final stages of platelet production from their precursor cell, the megakaryocyte (Mk). This is currently
at least 10 to 100-fold less efficient in vitro compared to in vivo. Overcoming this obstacle would therefore
represent a major step forward in developing in vitro methods for clinical scale platelet production. We
hypothesize that key spatially regulated signaling events occur when Mks engage the bone marrow vascular
sinusoidal niche, where they normally produce platelets in vivo. We also hypothesize that current in vitro platelet
production systems fail to adequately recapitulate these events. Further understanding these physiologic
signaling events is therefore key to advancing this field. Given the complex microenvironment in which these
events occur, it is critical to examine this problem in situ. The objective of this Stimulating Hematology
Investigation: New Endeavors II (SHINE-II) proposal is to adapt new spatial transcriptomic technology to study
gene expression events that occur when Mks interact with vascular sinusoids and begin producing platelets. It
will utilize Multiplexed Error-robust Fluorescence In Situ Hybridization (MERFISH), a technique that provides
sensitive and quantitative measurements of RNA expression of tens of thousands of genes in single cells while
at the same time providing spatial information regarding their expression in tissue slices. This will involve
developing MERFISH for the bone marrow vascular sinusoid using murine systems and pilot gene panels. This
will then be extended to whole-transcriptome scale and applied to human bone marrow samples. The functional
importance of select validated pathways will be explored using human CD34+ and hIPSCs in vitro differentiation
methods. Successful completion of the project will have a significant positive impact on the field by expanding
our knowledge of the physiologic signaling events that trigger Mks to mature and produce platelets in their natural
microenvironment. As the vascular sinusoid is also a key hematopoietic stem cell (HSC) niche and MERFISH
captures whole transcriptome gene expression measurements on all cells within the field, this project will also
provide a rich transcriptomic database for studies of HSC and vascular biology. The adaptation of MERFISH to
human formalin fixed paraffin embedded bone marrow biopsy specimens will also enable future in situ gene
expression studies of human bone marrow disorders.

Public health relevance
NARRATIVE A major goal in the hematology field is to produce platelets from stem cells in vitro (“in the test tube”) to overcome chronic shortages of donor platelets, yet current protocols are too inefficient for practical use. This proposal seeks to adapt new technology to identify the signals that normally trigger efficient platelet formation within the bone marrow and apply this knowledge to enhance in vitro platelet production. More broadly, this project will provide a powerful new tool to study normal blood cell development within the context of the complex bone marrow microenvironment and how it is perturbed in blood diseases such myelodysplastic syndrome, leukemia, bone marrow failure and genetic disorders.